Spatial analysis of regional, cell type and molecular hallmarks of Alzheimer's disease

ABSTRACT (PROJECT 3)
The molecular mechanisms underlying cellular vulnerability in Alzheimer’s disease are unclear. The objective
of this project is to clarify the molecular mechanisms responsible for select cell vulnerability and pathogenesis
by applying spatial methods for highly multiplexed RNA and protein analysis in Alzheimer’s-affected tissue
sections. We will optimize and standardize platforms for multiplexed fluorescence in situ hybridization (mFISH)
to examine AD-linked gene sets derived from single nucleus transcriptome analysis, as well as
immunohistochemistry (IHC) to examine pathological protein markers in the context of cell type populations in
intact human brain tissue. These methods will then be applied to Alzheimer’s disease tissues from brain
regions affected in different levels of disease severity to understand 1) the spatial organization of
transcriptomically-defined cell types in these brain regions and changes in this organization with disease
severity (e.g. selective vulnerability or proliferation), 2) molecular pathways disrupted in Alzheimer’s disease in
the context of specific cell types, and 3) the relationship between these affected cell types and the markers of
Alzheimer’s pathology, such as amyloid precursor protein and hyperphosphorylated tau. These data generated
by mFISH and IHC together will provide a high-resolution map of the cellular and molecular consequences of
clinically typical Alzheimer’s disease and an enhanced view of Alzheimer’s pathology, as well as a powerful
technology platform for future analyses of larger and more varied cohorts.

Public health relevance
PROJECT NARRATIVE (PROJECT 3) Alzheimer’s disease involves a predictable progression of neuropathological protein aggregation across brain regions. New highly multiplexed methods for fluorescent in situ hybridization (FISH) and immunohistochemistry (IHC), combined with detailed transcriptome-based classifications of cell types, offer a new high-resolution approach to understand selective vulnerability and resistance of different cell types to AD pathology. The goal of this project is to develop and apply highly multiplexed RNA combined with IHC methods to study quantitative changes in specific cell types with increasing AD severity, dysregulated molecular pathways in specific cell types, and relationships between pathological protein deposition and specific cell types in Alzheimer’s disease.